Automation Equipment for Human PET Radiotracer Production

PROJECT SUMMARY Funding is requested for automation equipment for human PET radiotracer production for use in the new cGMP production facility of the Institute for Innovation in Imaging (i3). The proposed instrument will be a crucial component in facilitating clinical research using Ga-68 based molecular probes with immediate applications in cancer, heart disease, and chronic diseases of the liver and lung. It will also enable the development and synthesis of novel molecular imaging probes and lower the barrier for their translation to human research. Finally, it would make Ga-68 readily available to local users on a daily basis. The automation equipment for PET radiotracer production will serve a large NIH-funded user community encompassing a wide variety of biomedical disciplines. We currently serve users both within the MGH/Harvard/MIT system as well as from around the greater Boston/Cambridge region. Ga-68 is an attractive isotope for use in PET imaging because it is readily available from a generator system (onsite cyclotron or reactor is not required), and the chemistry of Ga-68 based probes is very straightforward compared with other isotopes. The requested equipment would greatly expand our capacity to serve the local NIH-funded user community, as well as offer an important facility for rapidly expanding the user base with molecular imaging interests. In particular, the proposed instrument would allow for much more frequent use of existing Ga-68 based probes for human clinical research. The equipment would also make these and other probes readily available for preclinical imaging studies. Such studies are often not performed because they would require a dedicated radiochemist to prepare the probe, but with the requested equipment, these probes could now be purchased. The equipment would also allow for testing and validating new molecular imaging probes, and for developing them for human use. The automation equipment will accelerate the current research of 20 NIH-funded research programs supported by 4 NIH Institutes. Projects requiring the automation equipment for human PET radiotracer production include the use of PET image for studying (1) thrombosis, (2) pulmonary fibrosis, (3) cancers (prostate, breast), (4) response to tumor therapies, (5) heart failure, (6) hepatitis, (7) atherosclerosis, (8) Alzheimer’s disease, (9) neuroscience, and (10) stroke.

Public health relevance
PROJECT NARRATIVE The Institute for Innovation in Imaging was recently established to meet the overwhelming need at MGH to translate innovative imaging tools into the clinic. New research and development space for the Institute for Innovation in Imaging will be completed in early 2021 and house a cGMP PET radiotracer production facility for production of new imaging tracer translation into first in human studies. The proposed automated radiotracer production system will be a major resource for this facility to meet the needs of numerous NIH funded projects that strive to translate their research.